Regulation of the adaptive actin response by force-dependent bonds

Abstract
Force transmission through the actin cytoskeleton is fundamental to how cells sense the geometric and
mechanical constraints of their environments, move through tissues, remodel the extracellular matrix, and
regulate signaling receptors at the plasma membrane (PM) to determine cell fate. In systems such as the leading
edge of migrating cells or in clathrin-mediated endocytosis (CME), polymerizing actin pushes against a
membrane to generate protrusive force. The dynamics, structure, and force generation of actin are regulated by
mechanics and actin binding proteins (ABPs) that bundle, branch, break, soften, stiffen, polymerize, tether, or
move actin filaments. Aside from myosin motors, how mechanical force regulates the affinity of ABPs has seldom
been investigated. When ABPs are mechanically anchored in the cell, force at the ABP-actin interface regulates
the lifetime of the ABP-actin bond, which I refer to hereafter as the force-dependent actin dissociation rate
(FDADR). While intuition suggests the lifetimes of molecular bonds should shorten when the molecules are
pulled apart (a “slip bond”)1, a surprising majority of recently characterized ABPs involved in cell adhesion form
“catch bonds” with actin that increase in lifetime (sometimes >100-fold2) as force increases2–5. These bonds are
highly tuned to the direction of force applied relative to the actin filament polarity2,4,6 with the most extreme
reported example being the asymmetric catch bond formed by talin's ABS3 domain2. The functional impact of
the FDADR of these ABPs is not known. Due to actin's importance in generating and transmitting mechanical
force, equilibrium bulk measurements of ABP-actin interactions provide an incomplete picture of how ABPs
contribute to actin cytoskeleton structure, function, and regulation.
During CME the PM is bent to encapsulate membrane-bound cargoes. When PM tension is high, actin
polymerization force is required to bend the membrane and pull the nascent vesicle into the cell7. Actin at the
CME pit “adapts” to PM tension by localizing to the surface of the pit preferentially in conditions of elevated PM
tension (i.e., precisely only when it is required for CME completion)8. I will test the hypothesis that the THATCH
actin binding domains of CME adapter HIP1R forms an asymmetric catch bond like homolog talin ABS3. I will
discover mutants with altered binding in a yeast molecular-genetic screen and characterize their FDADR. I will
develop a stochastic simulation to uncover the role of the FDADR in actin network structure and function during
CME. I hypothesize that HIP1R's FDADR is tuned to selectively bind actin filaments that bear mechanical load,
thus supporting endocytosis over a range of membrane tensions amidst dense cortical filamentous actin. Mutant
HIP1R THATCH with altered FDADR will be expressed in mammalian cells, and their impact on CME and actin
organization will be determined and compared to simulations, thus relating FDADR to actin structure and
function.

Public health relevance
Narrative The actin cytoskeleton in cells produces and transmits forces that power cell movement, muscle contraction, and are important for how cells sense their surroundings. It is also required for transferring signaling receptors from the outer membrane into vesicles in the cell interior (endocytosis). I will study how the force-dependent actin bond made by the membrane protein HIP1R coordinates actin networks during endocytosis to understand how force-dependent bonds pattern actin for efficient force generation.